Health Outcomes of Parents with Cystic Fibrosis (HOPe:CF)

1 CF transmembrane conductance regulator (CFTR) modulators, a class of drugs that addresses the basic
2 defect in cystic fibrosis (CF), have led to large increases in the health and life expectancy of people with CF. In
3 turn, a large majority are now considering parenthood. The United States (US) CF Foundation Patient Registry
4 report (CFFPR) demonstrated a near-doubling of pregnancies in people with CF from 310 in 2019 to 619 in 2020.
5 Greater understanding of the health impacts of parenthood is critical to inform reproductive decisions and provide
6 effective interventions for those with CF who decide to become parents.
7 This co-funded application with the National Institutes of Health and the CF Foundation (CFF) will seek
8 to determine the health impact of parenthood on men and women with CF in the era of CFTR modulators. To
9 provide relatively immediate evidence on parenthood’s effect on pulmonary health and the influence of the intro-
10 duction and use of all available CFTR modulators, in Aim 1 we will assess changes in pre- vs. intra-parenthood
11 percent predicted forced expiratory volume in 1 second (ppFEV1) in a retrospective longitudinal cohort study
12 linking CFFPR data with cross-sectional surveys collected from 249 new parents attending participating US CF
13 centers between 2011-2020. We will identify predictors and timing of lung function loss using 747 non-parents
14 from participating centers as a comparison group and examine the impact of CFTR modulators on parental
15 health. In Aim 2, we will prospectively collect physical and mental health data to comprehensively evaluate the
16 impact of parenthood in CF with widespread highly effective CFTR modulator use. We will follow 146 new parents
17 of children <5 years of age over 5 years to assess the primary outcome of ppFEV1 change. To model potential
18 confounding/effect modification on the association between parenthood and outcomes, we will combine objective
19 physical health data and survey assessments of mental health, parental responsibility/stress, quality of life, and
20 adherence. We will conduct dyadic interviews with a subset of parents and their key supports to explore the
21 parenthood experience and identify future interventions. This study of the CF population would be the first, large-
22 scale epidemiologic data collection of how becoming a parent interplays with having a chronic disease.
23 Dr. Kazmerski, the principal investigator, is a pulmonologist and health services researcher with exper-
24 tise in sexual and reproductive healthcare for people with pediatric-onset chronic disease. The results of this
25 long-term, observational study will determine whether parenthood adversely impacts the health of people with
26 CF and the ability of CFTR modulators to mitigate such effects. Healthcare providers can use the data to pro-
27 vide evidence-based guidance to help those with CF make informed parenthood decisions. Future interven-
28 tions targeted to identified modifiable risk factors and high-risk time periods can be developed and tested to
29 prevent poor parental health outcomes. This work is aligned with the missions of the National Heart, Lung, and
30 Blood Institute and CFF as it improves the comprehensive care and quality of life for people with CF.

Public health relevance
PROJECT NARRATIVE As more people with cystic fibrosis (CF) live longer and healthier lives due to the advent and use of effective CF modulator therapies, a growing number are considering parenthood. However, minimal information exists about how parenthood affects those with CF, limiting the ability to make informed reproductive decisions and to support those who decide to become parents. This long-term, multicenter, observational study will determine the health impact of parenthood on men and women with CF in the era of CF modulators and is the first, large- scale epidemiologic data collection of how becoming a parent interplays with having a chronic disease.